Reducing Racial and Ethnic Disparities in Maternal Health through Policy Interventions

The long-term goal of the proposed research project is to improve the health of minoritized racial and
ethnic birthing people by reducing racial and ethnic disparities in severe maternal morbidity and maternal
mortality. Specifically, the proposed research project will assess the effectiveness of 3 significant health
insurance expansion policies in reducing racial and ethnic disparities in severe maternal morbidity
(SMM): 1) the 2010 Dependent Coverage Provision under the Patient Protection and Affordable Care Act
(ACA), requiring private health insurers to allow young adults to remain on their parent’s plan until their 26th
birthday; 2) the 2014 ACA Medicaid expansion, giving states the option to expand Medicaid coverage to non-
elderly adults with incomes up to 138% of the Federal Poverty Level; and 3) the Maintenance of Effort of the
2020 Families First Coronavirus Response Act (FFCRA) temporarily maintaining Medicaid coverage beyond
60-days postpartum as long the COVID-19 Public Health Emergency is in place.
Minoritized racial and ethnic birthing people are three times more likely than non-Hispanic White people
to experience SMM during childbirth and the postpartum. Addressing racial and ethnic disparities in SMM
is recognized as an urgent public health priority. SMM refers to unintended serious complications of labor
and delivery and is associated with substantially increased risk of maternal death. Providing continuous health
insurance coverage through health policies, from preconception to 1-year postpartum, is a suggested
intervention to mitigate these disparities. Up to 80% of minoritized racial and ethnic birthing people do not have
such continuous coverage. However, evidence linking health insurance policy changes to reduced racial
and ethnic disparities in SMM is scant. The 2010 ACA Dependent Coverage Provision, the 2014 ACA
Medicaid expansion, and the 2020 FFCRA Maintenance of Effort present three natural experiments for
assessing the effectiveness of expanding health insurance coverage in reducing racial and ethnic disparities in
SMM. The proposed project will test a series of hypotheses related to the specific aims, including: 1) Expanded
access to private health insurance for people under age 26 is associated with reduced racial and ethnic
disparities in SMM; 2) Expanded Medicaid coverage for low-income people is associated with reduced racial
and ethnic disparities in SMM, and 3) Extending Medicaid coverage for low-income people from 60-day to 1-
year postpartum is associated with reduced racial and ethnic disparities in postpartum SMM. National and
state data from the Healthcare Cost and Utilization Project, Agency for Healthcare Research and Quality, will
be analyzed using robust quasi-experimental approaches such as the difference-in-difference-in-differences.
Results of this project will help close important gaps in health disparities research and provide
rigorous evidence to inform policy interventions to reduce racial and ethnic health disparities among
birthing people. It aligns with the aims of the IMPROVE initiative of the National Institutes of Health.

Public health relevance
Addressing racial and ethnic disparities in maternal health is a national priority. The proposed project aims to assess the effectiveness of the 2010 Patient Protection and Affordable Care Act and of the 2020 Families First Coronavirus Response Act in reducing racial and ethnic disparities in severe maternal morbidity.